TEMPORAL-CALLOSAL PATHWAY DIFFUSIVITY PREDICTS PHONOLOGICAL SKILLS IN CHILDREN

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The development of skilled reading requires ef[unreadable]cient communication between distributed brain regions. By using diffusion tensor imaging, we assessed the interhemispheric connections in a group of children with a wide range of reading abilities. We segmented the callosal [unreadable]bers into regions based on their likely cortical pro jection zones, and we measured diffusion properties in these segmented regions. Phonological awareness (a key factor in reading acquisition) was positively correlated with diffusivity perpen dicular to the main axis of the callosal [unreadable]bers that connect the temporal lobes.